Mentoring in Sex and Gender-informed Multidisciplinary Research on Cardiometabolic Comorbidities in Persons with HIV

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease (CVD) accounts for significant morbidity and mortality among persons living
with HIV (PWH) on antiretroviral therapy (ART). Compared to HIV-seronegative individuals, PWH experience
higher risk of acute myocardial infarction, sudden cardiac death, and progression of subclinical carotid
atherosclerosis; further, women with HIV have a higher relative risk of CVD compared to men with HIV. Viral-
induced inflammation and immune activation play a prominent role in increased CVD risk among PWH. HIV
persistence due to latent reservoirs in the periphery and the gut is suspected to contribute to this inflammation.
However, our understanding of the underlying pathophysiologic mechanisms of cardiometabolic diseases in
PWH is limited; similarly, whether these mechanisms differ by sex has yet to be elucidated. With women
accounting for >50% of an aging global HIV population, it is critical to train the next generation of HIV scientists
to become leaders in sex and gender-informed HIV cardiometabolic comorbidity research.
As an Associate Professor of Medicine in the Emory Division of Infectious Diseases, my NIH-funded
research and successful mentorship program over the last decade has examined factors that contribute to
obesity and cardiometabolic comorbidities in the setting of chronic HIV with a focus on women and sex
differences. Leveraging tight collaborations with experts in high-resolution metabolomics (HRM), lipidomics,
HIV persistence, and T cell immunology as well as an established longitudinal cohort of PWH with >50%
representation of women and detailed HIV reservoir and subclinical CVD profiling, two new research aims are
proposed: 1) Assess relationships between the metabolome, lipidome, HIV reservoir, and subclinical CVD by
sex, and 2) Determine sex-specific multi-omic signatures associated with an increased risk of subclinical CVD
by HIV reservoir size. Through this K24 award, my specific career objectives are to 1) enhance my knowledge
of lipidomic and HRM methodologies to identify markers of CVD risk in persons with HIV (AIM 1); 2) increase
my understanding of multi-omics integration analyses to uncover mechanisms driving CVD (AIM 2); 3) expand
my understanding of the intersection of sex and gender science (all AIMS), and 4) improve the structure and
quality of my patient-oriented research mentoring program.
The proposed new research and training plan would provide essential insight into the use of HRM,
lipidomic and multi-omic integrative analyses to increase our understanding of relationships between the HIV
reservoir and development of CVD in PWH by sex. These new methodologic skills would enhance my current
research program and career development, provide robust training opportunities for mentees, and advance the
development of new preventative strategies to reduce the burden of CVD among PWH.

Public health relevance
PROJECT NARRATIVE While cardiovascular disease (CVD) is a leading cause of serious non-AIDS events and death in persons with HIV (PWH) despite antiretroviral therapy, we have a limited understanding of the underlying pathophysiologic mechanisms of CVD in PWH and the impact of sex and gender. Through this K24 award, my career objectives are to broaden my knowledge in the field through the integration of metabolomic, lipidomic and multi-omic methodologies, strengthen my understanding of the intersection between sex and gender science, and leverage my research infrastructure to build an impactful mentoring program to guide the next generation of leaders in multidisciplinary patient-oriented HIV research on cardiometabolic comorbidities.